Optimizing Care to Prevent Diabetes and Promote Cardiovascular Health Among Younger Adults with Severe Mental Illness

PROJECT SUMMARY
People with severe mental illness (SMI) face double the risk for type 2 diabetes compared to the general
population, contributing to higher rates of cardiovascular disease and premature death. Common use of
antipsychotic medications contributes to these health risks due to prevalent metabolic side effects. Many
younger adults with SMI do not receive targeted, evidence-based cardiometabolic disease prevention care.
Underused strategies include: prescribing alternative, less obesogenic psychotropic medications; lifestyle
change supports; additional risk-reducing medications; and smoking cessation therapies. Our preliminary
qualitative data with patients and clinicians identified a need for tools to match prevention care to individuals’
risk level and preferences, and tools suited to population-based care strategies. Clinical Decision Support
(CDS) tools are computer algorithms that use patients’ data, predictive analytics, and clinical guidelines to
promote evidence-based care by helping patients and clinicians navigate complex treatment decisions.
Through this mentored K23 career development award, Esti Iturralde, PhD will build upon her background as a
clinical psychologist and behavioral diabetes researcher. Through planned mentoring, coursework, and career
development activities, Dr. Iturralde will gain a strong understanding of psychopharmacology and
cardiometabolic health, advanced predictive analytics, and implementation science, including methods for
stakeholder-engaged intervention design and pragmatic clinical trials. As a researcher in the Kaiser
Permanente Northern California (KPNC) Division of Research (DOR), she will leverage robust, longitudinal
electronic health record (EHR) data (> 50,000 adults from diverse racial/ethnic groups) and stakeholder
insights (patients, clinicians, and health system decision-makers) within health systems including KPNC and 2
others belonging to the NIMH-funded Mental Health Research Network (HealthPartners Institute and Henry
Ford Health System). The proposed research will support the training goals while contributing to the
development of a novel CDS tool seeking to increase targeted, evidence-based diabetes and cardiovascular
disease prevention care for adults under age 45 who are starting antipsychotic medications. Specific research
aims are to: (1) inform predictive analytics of the CDS tool by developing and validating diabetes risk prediction
models for the target population; (2) engage stakeholders in the design of CDS tool messaging and
implementation pathways; and field-test CDS tool messaging through a pragmatic clinical trial conducted within
an existing KPNC telehealth-based population management program serving this population. A future R01
application will build on the results from this project to further refine and test the CDS tool within multiple health
systems. The linked research and training aims will directly prepare Dr. Iturralde for success as an embedded
health system researcher and prepare her to lead a programmatic line of studies developing and implementing
data-driven, feasible, scalable interventions improving the cardiometabolic health of people with SMI.

Public health relevance
PROJECT NARRATIVE Younger adults with severe mental illness (SMI) seldom receive targeted, evidence-based strategies intended to prevent diabetes and related cardiovascular complications, despite heightened risk for cardiometabolic disease. Clinical Decision Support (CDS) tools are computer algorithms that use patients’ data, predictive analytics, and clinical evidence to help patients and clinicians navigate complex treatment decisions. The proposed research will create the foundations for a novel CDS tool seeking to promote cardiometabolic disease prevention care for adults with SMI under age 45 who have recently started antipsychotic medications (a diabetes risk factor) through the following activities: (1) development of diabetes risk prediction models based on > 50,000 electronic health records for individuals in this population; (2) engagement of patient, clinician, and health system leader stakeholders in designing CDS tool risk/recommendation messaging and implementation pathways; and, (3) testing the feasibility, acceptability, and preliminary clinical effects of using CDS tool messaging within an existing telehealth population management program serving adults with SMI.